Enhanced Sensitivity and Quantitative Precision for Single Cell Proteomics

Single cell proteomics (SCP) is rapidly emerging and can quantify > 1000 proteins per cell.
Significant advances in instrumentation and sample preparation are making SCP more broadly
accessible. Yet technical advances in data acquisition have not been paired with advances to
computational tools. Algorithms for proteomics were designed and optimized on data from bulk
proteomics, and are ill-suited for SCP data. Our preliminary research shows that data from SCP
lack many features that are critical for current proteomics algorithms. We will dramatically
improve accuracy and coverage of the single cell proteome through creation of the first-ever
dedicated SCP search software. This will be coupled with an initiative to improve SCP peptide
and protein quantification. These algorithmic improvements will be informed from a large corpus
of SCP data, gathered and centralized into the first SCP data archive.

Public health relevance
Single-cell proteomics (SCP) has potential to revolutionize biologist’s understanding of how individual cells function in complex systems. SCP in its current state provides a shallow profile of cellular proteins and quantitative values with high variance. This proposal describes the first ever dedicated software for SCP analysis and should greatly improve sensitivity for peptide detection and improve accuracy for quantification.